Defining the molecular and anatomical basis of the blood-olfactory barrier (BOB)

The upper respiratory tract is lined by two distinct types of epithelium. Respiratory epithelium humidifies and
modulates incoming air temperature as it passes toward the lungs. Olfactory epithelium on the other hand is
specialized for chemosensation and supports detection of airborne odorants by olfactory sensory neurons
(OSNs). We have recently described that blood vessels within the olfactory mucosa form a “blood -olfactory
barrier” (BOB) that prevents high molecular weight blood borne proteins from accessing the olfactory tissues.
This BOB effectively isolates olfactory tissues from blood borne molecules in much the same way that the
blood brain barrier and the blood retinal barrier function in the brain and eye. In our studies we found that
antibodies (~150kD) against viral pathogens cannot exit the blood to prevent infections within the olfactory
epithelium. The existence of the BOB may help reconcile years of seemingly contradictory upper airway
immunity data, and also helps explain why pathogens such as SARS-CoV-2 that infect the olfactory epithelium
cause “breakthrough infections” when blood antibody titers are high. We know very little about the basic
cellular and molecular building blocks of this newly defined vascular barrier. This proposal will establish the
limits of BOB homeostatic permeability and several foundational insights about the BOB, including: BOB
functionality from developmental stages until late adulthood, determine the cellular and junctional makeup that
generates the BOB, define the functional permeability limits during health and inflammation, and finally
determine the role of olfactory neurons in orchestrating olfactory barrier identity.

Public health relevance
Relevance: This proposal will provide foundational understanding of a newly discovered va scular barrier within the upper respiratory tract. The brain-olfactory barrier (BOB) prevents large molecules such as antibodies from accessing olfactory tissue and therefore has implications for host defense and vaccinology as well as olfactory function, CNS protection, and drug delivery. Defining the core qualities and components of the BOB are essential to provide understanding the how regulating plasma protein access to the olfactory tissue is critical to olfactory biology and CNS health.